Therapeutic drug monitoring for linezolid in the treatment of rifampin-resistant tuberculosis: a pragmatic randomized controlled trial

PROJECT SUMMARY
Drug-resistant tuberculosis (TB) is a major global epidemic and poses a particular threat to people living
with HIV. With limited effective drugs available for treatment, multidrug-, and extensively drug-resistant TB
carry a high mortality rate and threaten global TB and HIV control efforts.
New and repurposed medications have recently been found to improve survival and cure rates. Linezolid—
a drug initially developed for the treatment of Gram-positive infections—has considerable anti-TB activity and
has been at the center of this treatment revolution. Since 2018, WHO has recommended that all rifampin-
resistant (RR-TB) TB treatment regimens include linezolid. When given long-term, however, linezolid-
associated toxicity—particularly myelosuppression and peripheral neuropathy—is very common, affecting 50-
80% of patients and often requiring a temporary or permanent discontinuation of therapy. Such interruptions
put patients at risk of treatment failure and the emergence of additional resistance to linezolid or one of the
other drugs in the regimen. As linezolid use continues to increase worldwide, such resistance could become
widespread, squandering a valuable medication.
Our group has previously shown that linezolid toxicities are associated with trough plasma concentration.
Further, linezolid has a narrow therapeutic window and considerable inter-individual variability. We therefore
hypothesize that identifying those with higher linezolid concentrations using therapeutic drug monitoring (TDM)
may allow pre-emptive dose reductions that could avert drug toxicity and premature discontinuation.
We propose a pragmatic, randomized clinical trial to determine the efficacy of TDM in preventing premature
discontinuation of linezolid. We will enroll 280 participants with rifampin-resistant TB (RR-TB) at our research
site in South Africa and will randomize them to receive TDM or standard of care (SOC). Participants in the
TDM arm will have their linezolid dose reduced if their trough concentration is greater than 2.5 mg/L, while
those in the SOC arm will have their linezolid adjusted or held only if they develop clinical adverse events.
Participants will be followed for the 6-month duration of RR-TB therapy. In Aim 1, we will compare the rates of
premature linezolid discontinuation between the two arms. All participants will receive identical screening for
linezolid toxicity at each visit, and in Aim 2, we will compare the incidence of hematologic and neurologic
toxicities between the two groups. In Aim 3, we will use population PK modeling to explore the complex
relationship between linezolid pharmacokinetic parameters and the trajectory of toxicities over time. We will
also determine whether those whose dose is lowered still meet exposure targets for drug efficacy.
South Africa has among the highest global burden of drug-resistant TB and HIV and has led the world in
the rollout of new RR-TB drugs and regimens. The aims of this study will answer fundamental questions about
linezolid pharmacology that will directly inform its use in South Africa and worldwide.

Public health relevance
PROJECT NARRATIVE Linezolid is a key drug in the treatment of rifampin-resistant tuberculosis (RR-TB) but side effects, including bone marrow suppression and peripheral neuropathy, are extremely common with prolonged use. Therapeutic drug monitoring (TDM), in which patients’ dose of linezolid is lowered if they have an elevated plasma drug concentration, has the potential to prevent linezolid-associated toxicity and premature discontinuation of therapy. This pragmatic, randomized controlled trial will evaluate the efficacy of linezolid TDM in patients with RR-TB in South Africa; the study addresses a common and urgent clinical dilemma in an effort to optimize use of this critical medication.